Administrative Core

Administrative Core Project Summary
CSDE seeks to advance population science and the understanding of human population processes in five
primary research areas: Demographic Measurements and Methods; Environments and Populations; Health of
People and Populations; Migrations and Settlements; Wellbeing of Families and Households. CSDE's
Administrative Core is the organizational hub that connects and coordinates with all of the other cores, the
executive leadership team, the Primary Research Area Chairs and faculty affiliates, and collaborating partners
across campus. CSDE's Administrative Core (AC) now (1) manages and coordinates all administrative needs
for all cores (hiring, budgeting, reconciliations, institutional compliance with all UW, state and federal
regulations, and other record keeping) so that the staff of other cores can focus on their primary missions; (2)
provides all grants management budgets, reconciliations, and reporting for all affiliates' grants managed
through the center; (3) coordinates, generates, and maintains all information gathering, website information,
databases and reporting via several virtual platforms and print publications on behalf of the entire center,
PRAs, and individual affiliates; (4) secures resources and makes investments for center-wide and PRA-specific
activities that build communities and collaborations among CSDE's affiliates to stimulate new research and
advance population science; (5) provides logistics, coordination, and leadership for all outreach events; (6)
manages the outreach and institutional onboarding of all affiliates, including external affiliates, and including
record keeping; and, (7) coordinates all core and center-wide evaluation and assessment activities, including
progress report, affiliate surveys and reports, and deans' reports.